Primary Amines as Versatile Precursors for the Synthesis of Bioactive Molecules and Macromolecular Drug Carriers

Project Summary/Abstract
The invention of new therapeutics is a multidisciplinary endeavor in which chemistry plays a crucial
role. Following the discovery of a target responsible for a disease—generally a protein—chemists are tasked to
provide small-molecule inhibitors or agonists that will selectively bind to the target receptor and induce a
cascade of molecular events responsible for improving the patient’s condition. Identification of a drug candidate
combining potency, efficacy, low toxicity, and desirable pharmacokinetics requires an intense synthetic effort
during which thousands of molecules are created by diversification of a bioactive scaffold. In order to support
these drug discovery campaigns, there is a constant need to invent new methods allowing for selective
modifications of complex molecules including peptides, carbohydrates, and other natural products. Once a
drug candidate is nominated, chemists need to devise a scalable process route that meets cost, safety, and
FDA requirements, which is another opportunity for chemical innovation. Some pharmaceuticals might have
poor physical properties and/or stability, which might necessitate the development of polymeric drug-delivery
systems to fully achieve their potential. These intricate macromolecules represent another type of synthetic
challenge since they are designed to release their cargo upon external stimulation, for example, via a subtle
pH or temperature change. This research program seeks to deliver new methods of widespread interest and to
illustrate their relevance to pharmaceutical research by delineating efficient syntheses of challenging small
molecules and stimuli-responsive polymers.
The overarching theme of this proposal is the transformation of primary amines—one of the most
ubiquitous groups in natural and synthetic molecules—into a variety of linkages including C–C, C–H, C–F, and
C–B bonds via C–N activation. In the first section, a click reaction will be developed to transform primary
amines into sulfamides. These rather exotic groups will be investigated as hydrogen-bond donors in polymeric
and bioactive molecules, as well as precursors for a C–N activation platform. Furthermore, as a click linker,
sulfamides will serve to selectively functionalize peptides and aminoglycosides. A collaboration will also be
launched to develop this reaction as a tool for peptide macrocyclization. The second section explores the
potential of sulfamides as progenitors of radical pairs, whose subsequent recombination will afford an array of
aliphatic C–C bond formations. The last section hypothesizes that sulfamides can also be transformed via
transition-metal catalysis, which would open the door to (hetero)arylation, fluorination, and borylation reactions,
among others. These mechanistically distinct C–N activation processes will be applied to the functionalization
of bioactive molecules and polymeric architectures for drug delivery.

Public health relevance
Project Narrative Primary amines are ubiquitous in natural products and synthetic molecules. This proposal aims to transform this universal moiety into a variety of linkages for the synthesis of bioactive small molecules and polymer architectures. These methods will help the discovery of drug candidates and potential drug delivery systems, and shed light on underexplored reaction mechanisms